Admin Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATION
The Administrative Office of the Tisch Cancer Institute (TCI) provides dedicated and effective administrative
support to the Center Director, Deputy Director, Associate Directors, Program Leaders and Shared
Resources Leaders. The overall goal is to facilitate collaborative and innovative cancer research through
strong operational and financial management of TCI resources. Operational management includes providing
support for processes related to decision-making, shared resources, membership, pilot awards, space
assignment and faculty recruitment/retention. Financial management includes oversight of all cancer center
funds including the CCSG grant, gift accounts, faculty start up packages, institutional budgets and cancer
clinical trial accounts. Tisch Cancer Institute administration is widely recognized as an established and
independent entity within Mount Sinai, superior to that of a department, and works closely with the offices
within the Icahn School of Medicine at Mount Sinai (ISMMS) and Mount Sinai Health System, including
Administration, Finance, Grants and Contracts Office, Business Planning, Human Resources, Information
Technology and Development to facilitate the vision and goals of the cancer center.